TRAINING IN MOLECULAR BIOPHYSICS

Use continuationpagesas neededto providethe requiredinformationin theformat shownbelow. Startwith PrincipalInvestigator.Listallotherkey personnelin alphabeticalorder,last namefirst. Name Organization Roleen